MAINTENANCE FOR MODEL 204 DATA BASE MGMT SYSTEM (DBMS)

The Contractor shall provide maintenance support services for the Model 204 Data Base Management System (DBMS) residing on the NLM owned IBM 3090-300J processor machine. Maintenance support services shall consist of error corrections, product enhancements (updates) and hotline services.